A DUAL CHIMERIC HUMAN ASTROGLIAL-MICROGLIAL MODEL OF HIV AND HAND

Abstract Synaptic failure is an important feature of HIV infection of the brain, and a likely key contributor to HIV-
associated neurocognitive disorders (HAND). Yet current animal models have proven of limited utility in defining
the mechanisms of this process, in part because of the species-specific nature of HIV infection, but also because
of the greater complexity of human astrocytes relative to those of mice. To address this issue, we will utilize mice
chimeric for both human microglia and human astrocytes, to assess the effects of HIV infection on central
neurons. To that end, we will engraft mice with both human glial progenitor cells (hGPCs) and microglia, each
derived from embryonic stem cells (hESCs). We have established the methods of generating these human glial
chimeras, by the neonatal implantation of hGPCs, which outcompete and ultimately replace the host mouse
GPCs, yielding adult chimeras broadly colonized with human astroglia1-5. This process is especially robust in the
neostriatum, allowing the glial humanization of regions critically involved in striatal reward and addiction circuits.
We have recently extended this approach to include chimerization with hESC-derived microglia, paired with the
use of CSF1R null mice lacking host microglia, crossed to NSG SGM3 mice to allow the stable xenograft of
hGPCs. The mice are thus chimeric for hGPC-derived astrocytes as well as microglia, in a T- and B-cell deficient
background that allows the effects of glial HIV infection on neurons to be isolated, following intracerebral
inoculation with HIV-infected microglia. These chimeric human astroglial-microglial (CHAM) mice are especially
attractive, since they incorporate the hominid-specific features of human astroglia, which are themselves key
components of central synapses. Using this model, we will test the postulate that astrocytes become both
structurally and functionally impaired by microglial HIV infection, resulting in the loss of synaptic engagement by
affected astrocytes, with consequent dendritic involution and network disruption. By infecting CHAM mice with
HIV, and using rabies viral-EGFP to trace striatal dendrites, we will assess the effects of astrocytic HIV infection
on the dendritic architecture and synaptic structure of resident medium spiny neurons. In parallel, we will study
the effects in CHAM mice of HIV infection complicated by methamphetamine use – a common and disabling
comorbidity that suppresses dopaminergic input to the striatum – focusing on the structural and transcriptional
responses of human glia to the combination of infection and addiction, as well as on the behavioral effects of
that combination. To that end, we will use single cell RNA-Seq to assess the changes in gene expression by
human astrocytes and their partnered mouse neurons caused by HIV infection, both alone and together with
chronic methamphetamine use, to identify those changes that contribute to the striatal synaptic disruption and
behavioral pathology of these mice. Our goal is to test the hypothesis that the HIV-infected striatum, by virtue of
astrocytic fiber disengagement from dopaminergic synapses in particular, is especially vulnerable to the effects
of amphetamine abuse, while defining the transcriptional basis for the glial pathology underlying that vulnerability.

Public health relevance
Project Narrative Astrocytes and the glial progenitors from which they derive are the most abundant cells in the human CNS, and modulate both the structure and function of neural networks; they are also potential reservoirs of CNS HIV infection, which is itself associated with deficits in cognition that may both persist and progress, despite optimal control of systemic infection. Nonetheless, because of HIV1's phenotype-specific and species- selective virulence, it has been difficult to study human HIV1 infection, or its associated neurocognitive disorder, in animal models in vivo. To address this issue, we propose to use mice neonatally-transplanted with human ESC-derived glial progenitor cells and microglia - in which most host glial progenitors, and a large fraction of astrocytes and microglia, are ultimately replaced by human cells - to assess the effects of striatal HIV1 infection – with and without chronic exposure to methamphetamine, a common drug of abuse in HIV - on human astroglia, and ultimately on the structure, transcription and behavioral output of striatal neurons in the HIV1-infected brain.